Development and utility of a wearable sensor for continuous monitoring of nutrients and hormones in subjects with chronic kidney disease

PROJECT SUMMARY
Circulating nutrients, metabolites and hormones are both useful biomarkers for risk assessment and causal
agents of chronic diseases including obesity, diabetes, hypertension, chronic kidney disease (CKD) and cancer.
The current methods for monitoring nutrients and hormones involve measurement of concentrations in blood
samples and/or body fluids using benchtop instruments, such as automated Bioanalyzers and liquid
chromatography–mass spectrometry (LC-MS) stationed in Clinical Diagnostic Labs, leading to discomfort and
high costs associated with repeated measures. Recent advances in continuous glucose monitoring in skin
interstitial fluid (ISF) have revolutionized the study of Precision Nutrition/Medicine and Circadian metabolism,
due to the wearable nature and continuity of monitoring. Because of the costs associated with CKD progression
(7% of Medicare expenditures) and the associated morbidity and mortality, the development of tools to
continuously monitor nutrients, metabolites and hormones beyond the continuous glucose monitor is highly
desirable in order to alter the course of CKD progression. It is therefore proposed to develop an innovative
wearable multimodal sensing system for continuous monitoring of nutrients (sodium, potassium and calcium)
and hormones, including 25OH Vitamin D (VitD), intact parathyroid hormone (iPTH), and fibroblast growth factor
23 (FGF23). This high-risk/high-reward approach is fundamentally different from traditional method of periodic
blood sampling for the trending of lab values and correlation with other clinical parameters. In the R21 phase
(exploratory), wearable multimodal sensors will be developed for continuous monitoring of nutrients and
hormones. The wearable sensors will be developed modeled on aptamer-based biosensors for continuous
monitoring of individual small molecules and a minimally-invasive, microneedle-based potentiometric sensor for
multiplexed and continuous monitoring of nutrients (sodium and potassium). In Aim 1, we will adapt and build on
these biosensors for continuous monitoring of three nutrients (sodium, potassium and calcium) and three
hormones (iPTH, FGF23 and VitD), simultaneously. A miniaturized print circuit board and associated electronics
for wireless data communication with a smartphone App will be developed. In Aim 2, a deep recurrent neural
network approach for joint multi-modal sensor data calibration will be utilized and the utility and reliability of
wearable sensors validated in rat models. The R33 phase (Clinical Trial) will be undertaken based on achieving
well-defined milestones in the R21 phase. In Aim 3, the device will be further refined and the ranges of skin ISF
hormones in human subjects established. In Aim 4, the contribution of diet on nutrients/ hormones concentrations
will be assessed and machine learning algorithms developed to predict CKD progression. The overall goal of
these studies is to develop an innovative wearable multimodal sensing system for continuous monitoring of
nutrients and hormones. This will set the stage for future work wherein these and other nutrients/hormones
critical to chronic diseases can be modified, thereby fulfilling the promise of Precision Nutrition.

Public health relevance
PROJECT NARRATIVE Wearable biosensors are desirable for continuous monitoring of nutrients and/or hormones in humans for maintaining health and to predict disease onset and progression. Several nutrients and hormones interact in known and unknown ways to lead to incidence and progression of Chronic Kidney Disease and ultimately End Stage Kidney Disease/Dialysis. This proposal will develop a wearable biosensor and algorithms to predict Chronic Kidney Progression by integrating the daily fluctuations in six nutrients and hormones and their interactions over the long term via machine learning methods.